Systematic Identification and Functional Characterization of Alternatively Spliced Exons with Phenotypic Relevance

Our primary objective is to systematically identify and characterize alternative exons with significant phenotypic impact. Using innovative functional genomics platforms-including orthogonal exon deletion and splice site mutagenesis-we are dissecting the functional relevance of alternative exons at genome scale. By integrating massively parallel exon perturbation with cellular fitness assays, we have uncovered a large set of alternative exons that either promote or suppress cell proliferation. Fitness-promoting exons tend to occur in essential, highly expressed genes and frequently overlap protein domains or interaction interfaces. In contrast, fitness-suppressing exons are enriched in non-essential, low-expression genes, often exhibit low inclusion levels, and tend to map to intrinsically disordered regions and sites of clinical mutations. As a case study, we investigated TAF5 alternative exon 8, a fitness-promoting exon whose inclusion regulates assembly of the TFIID transcription initiation complex and downstream gene expression. We further showed that exon 8 inclusion is modulated by the splicing factor SRSF1 and is dynamically regulated in response to genotoxic stress. To expand the resolution and throughput of exon functional studies, we developed scCHyMErA-Seq-a scalable CRISPR-based exon deletion screening platform integrated with 10x Genomics single-cell transcriptomic profiling. This technology enables efficient exon deletion while simultaneously capturing Cas9/Cas12a guide RNAs and polyadenylated transcripts at single-cell resolution. Applying scCHyMErA-Seq to the high-throughput profiling of alternative cassette exons, we identified numerous splicing events with strong regulatory effects on gene expression. For instance, analysis of NRF1 alternative exon 7 revealed that its inclusion modulates NRF1's recruitment to target gene promoters and thereby shapes transcriptional output. Importantly, transcriptional profiles derived from scCHyMErA-Seq closely mirror those from orthogonal, low-throughput approaches-offering both accuracy and scalability. Overall, scCHyMErA-Seq provides a powerful platform to systematically uncover the functional impact of alternative splicing by linking specific exon usage to transcriptional phenotypes. Moving forward, our goals are to: 1. Engineer advanced tools for high-throughput exon perturbation with diverse phenotypic readouts; 2. Identify phenotypically relevant splicing events through screens in clinically relevant models, including patient-derived renal cell carcinoma and bladder cancer systems; 3. Elucidate the functions of key alternative exons in gene expression regulators.